Contribution of the Parabrachial CGRP-Expressing Neurons to the Pathophysiology of Panic Disorder

Project Summary/Abstract
Panic disorder is a debilitating anxiety disorder that is characterized by sudden and recurrent attacks of
intense, uncontrollable anxiety and fear. This psychiatric illness is unique among other anxiety-related
disorders because individuals with panic disorder not only experience mental symptoms during an attack, but
they also suffer acute physical symptoms, including cardiorespiratory, autonomic, and gastrointestinal
symptoms. In addition, these panic attacks occur spontaneously, and are associated with innate unconditioned
fear (i.e., fear that has not been learned through an aversive experience). To understand what causes these
bouts of unconditioned fear and associated physiological symptoms in panic disorder, it is critical to
characterize the neural circuitry underlying innate threat perception. The lateral parabrachial nucleus (PBN)
within the brainstem regulates cardiorespiratory and autonomic functions, and also relays multimodal aversive
sensory signals to the amygdala. Preliminary data show that factors that induce panic attack in panic disorder
patients, such as caffeine, yohimbine or high CO2 levels, robustly activate neurons in the external lateral region
of the PBN (PBel) that express a particular neuropeptide, Calcitonin gene-related peptide (CGRP), and
activation of these neurons is necessary and sufficient for innate threat perception. However, little is known
about the circuit mechanism of the PBel CGRP-expressing neurons in panic disorder pathogenesis. To
address this problem, proposed experiments use state-of-the-art neural circuit dissection tools to MONITOR
and MANIPULATE the activity of PBel CGRP neurons, as well as target neurons that express the CGRP
receptor. The central objective of this proposal is to determine how PBel CGRP neurons respond to and
encode innate sensory threats, and how these neurons contribute to the unique physical and emotional
comorbidities in panic disorder. To achieve this objective, activity of PBel CGRP neurons will be monitored (via
in vivo calcium imaging) as mice are exposed to multimodal sensory threats or panicogenic agents (Aim 1).
PBel CGRP neurons will then be manipulated (inhibited or activated) using optogenetic and chemogenetic
techniques to establish causal relationships between CGRP neuronal activity and physiological changes during
innate threat perception (Aim 2). Lastly, activity of downstream neurons (those that express CGRP receptors in
brain regions innervated by PBel CGRP neurons) will be monitored and manipulated to establish functional
neural circuits involved in panic disorder pathogenesis (Aim 3). Contributions of the proposed research will be
significant because it will advance the circuit-level understanding of panic disorder pathogenesis. The research
plan is innovative because it investigates, for the first time, involvement of the PBel in panic disorder
pathogenesis using cell type-specific circuit dissection tools. Successful completion of the proposed research
will therefore provide neural circuit-based understanding of panic disorder symptoms, which may provide
important insights toward developing therapeutic interventions for panic disorder.

Public health relevance
Project Narrative Proposed research will reveal how specific neurons in the brain transform aversive sensory stimuli into threat- induced behavioral and physiological responses. Understanding this aspect of brain function will provide clues as to why individuals with panic disorder experience spontaneous bouts of anxiety and physical symptoms (e.g., cardiorespiratory and gastrointestinal) even in the absence of a genuine threat. This level of understanding will also identify potential ways of dampening these anxiety-driving neural pathways, which is the critical first step toward developing therapeutic interventions for panic disorder.